EFFECT OF PROTEIN MUTATION ON ACTIVE SITE STRUCTURE IN CYTOCHROME C

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Fe K-edge XAS data will be measured on the electron transfer protein cytochrome c (cytc). The c-type cytochromes that have histidine-methionine (His-Met) iron coordination play important roles in electron-transfer reactions and in enzymes. The axial methionine ligand plays a major role in stabilizing the protein and maintaining a low redox potential. Protein mutations of Pseudomonas aeruginosa (Pa) and Nitrosomonas europeae (Ne) cytc show differences in rhombicity (using EPR spectroscopy) in their active site, which have been linked to perturbations in the Fe-S(Met) bond. Fe K-edge EXAFS data (BL9-3) will shed light on specific geometric structure changes at the electron-transfer active site with changes in the protein environment. The experiments will be extended to S K-edge XAS (BL4-3) to obtain quantitative information on the Fe-S covalency.